EFFICIENT DIFFERENTIATION, SCALE-UP, AND MATURATION OF IPS DERIVED CARDIOMYOCYTES

Project Summary/Abstract
Cell expansion is a critical step for cell therapy, hindered by expensive and complex bioreactor requirements to
yield sufficient cell numbers for adequate dosing and requiring expensive regents to enhance functionality for
increased clinical success. Similarly, in-vitro models of cardiac disease using induced pluripotent stem cell
derived cardiomyocytes (iPS-CM) are of critical importance to understanding cardiac biology and disease in the
human setting. However, inefficient differentiations hinder the robust translation of these models from the bench
to clinically useful metrics. Similarly, iPS-CMs are inherently immature and represent fetal like phenotoypes more
than their adult counterparts of more relevance for clinical utility. Thus, there is a need for the reliable production
of iPS-CMs of high quality, yield, and maturity. To address this, Link provides low-shear pumpless perfusion
bioreactors contatining organotypic niches for the bulk culture of cells in controllable 3D aggregates for enhanced
delivery of nutrients, enhanced efficiency of directed differentiations, and increased viability and yeild due to
efficient gas and nutrient exchange. These bioreactors require significantly less media than similar bioreactors
and substantially less hand-on culture time than current manual workflows. Our devices are cost efficient and
simple to use, democratizing patient modeling and cell therapy for both patients, researchers and providers. The
increased efficiency of our developed device enables an increase in the patient pool by improving patient access,
availability, and applicability to more disease subtypes.

Public health relevance
Narrative In this Phase I SBIR, Link Biosystems, Inc. Overall, the Phase I is designed to demonstrate the feasibility of our OnXpansion technology to enable iPS-CM differentiation and expansion of enhanced quality and efficiency to enable the realization of precision medicine workflows. The OnXpansion bioreactor is user-friendly/automated, robust, and generates iPS-CM cells of high purity and viability. In the Phase II portion of the proposed SBIR, we will further streamline and deeply characterize OnXpansions utility to directly provide a closed, automated process for the manufacturing of mature patient iPS-CM cells at scale and derisk it’s utilization as a cGMP compliant bioreactor technology for the efficient generation of high maturity iPS-CMs at clinically relevant scales within academic research centers and companies offering cell therapy products.